Role of targeting ATPases BRG1/BRM in therapy of AML

Project Summary:
BAF (BRG1/BRM-associated factor) complexes are ATP dependent chromatin-remodeling complexes which
contain mutually exclusive, core ATPases, BRG1 (SMARCA4) and BRM (SMARCA2). The canonical (c) BAF
complex subunits bind and allow transcription factors (TFs) and co-factors to gain access to the chromatin and
modulate lineage-specific gene transcription in hematopoiesis. BRG1 is a dependency in AML cells, including
those with MLL rearrangement (MLLr) or mutant (mt) NPM1, representing 40% of adult AML. Although Menin
inhibitors (MIs) induce clinical remissions, most patients of AML with MLLr or mtNPM1 relapse with MI-resistant
AML, based on adaptive, dysregulated gene-expressions or hotspot mutations in Menin, abrogating MI activity
in AML cells. This creates a glaring unmet need to develop and test through preclinical studies novel targeted
agents and combinations with superior efficacy that can be advanced to the clinical setting in AML with MLLr or
mtNPM1. FHD-286 is the first in clinic (NCT04891757), potent, catalytic inhibitor, whereas AU15330 is the
PROTAC (Proteolysis Targeted Chimera) degrader of BRG1/BRM. Our preliminary studies demonstrate that
treatment with FHD-286 induces differentiation and lethality in AML cells, regardless of sensitivity to MI, but not
in normal progenitor cells. This compelling efficacy is associated with gene-expression perturbations responsible
for growth inhibition, differentiation, and depleted AML-initiating potential in patient-derived (PD) xenograft (PDX)
models of AML with MLLr or mtNPM1. FHD-286 monotherapy, and in combinations with standard and
investigational agents, also exerts potent efficacy in cellular models of AML harboring MLLr and mtNPM1 with
or without FLT3 mutations. Studies proposed here are supported by these compelling preliminary findings and
our access to the pre-treatment and upon-relapse AML cells from patients enrolled on MI monotherapy. These
studies are motivated by the overarching hypothesis that treatment with BRG1/BRM antagonist will undermine
dysregulated gene expressions and overcome differentiation-arrest, growth advantage and survival of AML cells,
as well as synergistically exert in vivo efficacy against PDX models of AML with MLLr or mtNPM1. The specific
aims of studies proposed are: Aim 1: To determine pre-clinical efficacy of BRG1/BRM antagonist (an inhibitor
or degrader) and associated perturbations in the epigenome and transcriptome, linked to the proteome,
evaluated as the gene-expression perturbation signature of BRG1/BRM antagonist activity in PD AML cells with
MLLr or mtNPM1 sensitive or resistant to MI treatment. Aim 2: To evaluate the pre-clinical efficacy of BRG1/BRM
antagonist-based novel combinations, utilizing in vitro MI-sensitive PD AML cells and in vivo PDX models of AML
with MLL1r or mtNPM1. Aim 3: To determine efficacy of BRG1/BRM antagonist-based combinations to
overcome MI-resistance due to epigenetic/adaptive mechanisms or Menin mutations in PD AML cells with MLL1r
or mtNPM1.

Public health relevance
Narrative: Studies proposed will determine the pre-clinical in vitro and in vivo efficacy and its embedded gene-expression signature of dual BAF complex ATPases BRG1/BRM antagonist in AML cellular models with MLLr or mutant NPM1. These studies will also determine BRG1/BRM antagonist-based novel combinations, including those with agents targeting co-dependencies nominated by CRISPR screens, that exert superior efficacy against PD AML cells with MLL1r or mtNPM1 sensitive or resistant to Menin inhibitor treatment.